Hybrid- and Multi-Cloud Storage Strategies for Cost-effective Deployment of Data Resources

PROJECT SUMMARY
The goal of the FaceBase III Hub, supported by the National Institute for Dental and Craniofacial
Research (NIDCR), was to create a data resource to serve the entire community of dental and
craniofacial researchers first by sharing diverse data related to craniofacial development and
dysmorphology and increasingly dental and translational research, as well as other research
that can benefit from the data that is in the FaceBase repository. FaceBase is home to over
1,040 imaging, genomics and other datasets, spanning human, mouse, zebrafish, chick with
prospective contributors in other species, and it has seen steady usage worldwide.
FaceBase is in the process of migrating from an on-premise infrastructure to the Amazon Web
Services (AWS) “cloud” service provider. While the cloud deployment of FaceBase will offer
many benefits to the community that it serves, one particular challenge facing FaceBase or any
other data resource operated on a commercial cloud is the incremental and unpredictable costs
of data storage and downloads.
In this project, we propose to explore hybrid- and multi-cloud storage strategies in order to
optimize for the most cost-effective storage providers and schemes available. We propose the
following specific aims: (1) leverage cost competitive specialized cloud storage service providers
to supplement core service deployment on AWS, and (2) explore the usage of on-premises
storage resources through a hybrid-cloud strategy to augment further our public cloud
infrastructure and seamlessly exploit subsidized low-cost storage infrastructure through our
institution.
The ultimate goals of the project are to accelerate dental, oral, and craniofacial research and to
advance the understanding of cost-effective utilization of cloud resources to benefit potentially
any NIH supported data resources.
PREVIEW Date: Apr 11, 2023 Workspace ID: WS01078345 Funding Opportunity Number: PA-20-272

Public health relevance
PROJECT NARRATIVE The FaceBase III Data and Analytics Hub (FaceBase) is funded by NIDCR to create a FAIR (Findable, Accessible, Interoperable, Reusable) data repository to enable a broad community of dental and craniofacial researchers by sharing diverse data related to craniofacial development and malformation. While the cloud deployment of FaceBase will offer many benefits to the community that it serves, one of the critical factors facing FaceBase or any other data resource operated on a commercial clouds is the incremental and unpredictable costs of data storage and egress (i.e., outbound data traffic) as the resource grows in data contributions and data usage volume. The mutli- and hybrid-cloud storage strategies to be explored in the proposed work will help FaceBase and other data resources minimize their resource expenditures by lowering the cost of their most volatile cloud pricing components – storage capacity and data egress.